Development and Validation of Gaze-based Training for Endoscopic Kidney Stone Surgery

Project Summary
The importance of achieving stone-free status during endoscopic kidney stone surgery is emphasized by the
high rate of repeat stone procedures due to residual fragments after index surgery. Speciﬁcally, residual stone
fragments can lead to obstruction, pain, kidney injury, and recurrent infections. Currently, of the 100,000 patients
who undergo an endoscopic kidney stone treatment each year, around 25,000 will require a repeat stone surgery
within 20 months. Successful endoscopic stone surgery requires the surgeon to visualize the entire renal col-
lecting system and locate all kidney stones during treatment. Challenges that lead to incomplete stone treatment
involve inadequate stone visibility and difﬁculty navigating through the kidney. Complete kidney navigation relies
on clinical experience and surgeons who have performed fewer cases have greater chances of recurrence.
Our overall goal is to create an eye gaze based guidance system to complement the current standard of care
where trainees only get verbal feedback. Gaze guidance has been shown to improve skill acquisition and retention
in robot-assisted and laparoscopic surgery settings but has not been explored in the unconstrained environment
of ureteroscopy. Our previous work in measuring eye gaze patterns shows similar differences in trainee vs.
expert gaze behavior during kidney stone phantom procedures compared to those found in laparoscopic and
robotic surgery. This suggested that using gaze training may similarly improve ureteroscopy skill acquisition.
Successful eye tracking and eye gaze sharing in ureteroscopy require a tracking and registration system that
does not constrain surgeons’ movements or head orientations. We propose head-mounted eye trackers that map
gaze to the surgical monitor to ﬂexibly track gaze as surgeons move around the operating room. We will evaluate
whether the gaze sharing platform improves complete kidney visualization, which is required to identify stones
that may not show up in pre-operative imaging, in phantoms and patients.
The endpoint of this R21 will be a fully validated gaze-based training system for endoscopic stone surgery and
the necessary experimental data to power a large-scale, multi-center clinical trial. As our training system is solely
composed of software running on augmented reality devices, all existing endoscopic and laparoscopic surgical
procedures could in principle immediately beneﬁt from the results of this project. In this way, we believe the suc-
cess of our project will facilitate improved training procedures and mitigate repeat interventions or complications,
beneﬁting patients, surgeons, and society.

Public health relevance
Project Narrative Each year, over 100,000 patients require endoscopic (i.e. minimally invasive) surgery for kidney stone disease in the United States. Approximately 25% of these patients require repeat surgery for residual stone fragments, which can lead to obstruction, pain, kidney injury, and urinary tract infections, with more inexperienced surgeons having a higher risk of repeat surgeries. This proposal aims to create an eye gaze sharing system to improve surgical training and guidance so that trainees acquire skills faster and beneﬁt more from an expert mentor’s experience.